A longitudinal study investigating TDM and adolescent health and development: Brain, Behavior and well-Being

PROJECT SUMMARY – OVERALL
This P01 program grant will establish a fully integrated interdisciplinary program of research Projects and
Scientific Cores that are essential to develop a fundamental understanding of the complex interplay between
adolescent health and development, and technology and digital media (TDM). Previous evidence has illustrated
TDM’s connections to adolescent risk behaviors such as increased alcohol behavior and social media exposure,
as well as relationships to adolescent well-being such as improved socioemotional health and peer social media
connections. The goal of the Projects described in this proposal is to address the urgent need to understand how
TDM exposure and usage affect multiple developmental domains and health outcomes. The three PIs are all
located at the University of Wisconsin-Madison, ensuring close collaboration and synergy, in addition to
outstanding institutional support and resources, including matching funds. The Projects include: Project 1: Using
TDM to understand mechanisms in adolescent health and risk behavior. Project 2: Using functional magnetic
resonance imaging to understand how positive and negative TDM experiences relate to mental and behavioral
health. Project 3: Using mixed methods to evaluate self- and other-generated TDM content as predictors of
socioemotional well-being in sexual and gender minority (SGM) and non-SGM adolescents. Each Project utilizes
a 2-year longitudinal design and draws from a shared participant pool. Data collection approaches across
Projects include observed/measured data including observed social media content and fMRI data, self-reported
participant experiences and perceptions via surveys and interviews, and Ecological Momentary Assessment to
capture real-time TDM exposures. To support this program, the Administrative Core (Admin Core) will provide
organizational and management support to arrange regular meetings across Program collaborators, involve
students in the research, leverage biostatistical support and promote dissemination. This P01 proposal will
include a Recruitment and Retention Core (R&R Core), supporting a shared participant pool across Projects,
and ensuring retention over time. This P01 program will promote synergy in these research efforts through
integrated data collection processes over a synergistic longitudinal design, aligned measures and a shared
participant pool so that analyses can be structured within and across Projects. This P01 proposal includes a
priority on dissemination of findings, both to scientific audiences and to the communities across Wisconsin to
reach those who participated in this research. Thus, this P01 program will enhance the scientific knowledge,
ideas and outcomes obtained through the interactions of the 3 Projects, the Admin Core and the R&R Core. This
proposed program will provide both the infrastructure support and the scientific approach necessary to advance
data-informed theories and conceptual models addressing how TDM exposure and usage impact developmental
trajectories and health outcomes of adolescents. Because of the broad potential for advancing research and
possible clinical translation of results, these connected Projects portend an opportunity to improve prevention
and intervention approaches for adolescent health and TDM.

Public health relevance
PROJECT NARRATIVE – OVERALL Technology and digital media (TDM) have impact on adolescents’ behaviors, well-being and their developing brains. In this P01 program proposal, we will collect data from adolescents over time leveraging several sources, including self-report, observed social media data and functional MRI. This integrated approach to longitudinal data collection from a shared adolescent participant pool will lead to novel analyses and findings, such that this P01 program will advance conceptual models and inform new interventions to improve adolescent health.